Revealing the crosstalk between one carbon metabolism, SAM availability and chromatin methylation

PROJECT SUMMARY
Early in my career I became intrigue by the fact that chromatin modifications included chemical modifications
that were dependent on metabolites, yet very little was known on how cells connected metabolic input to
chromatin reactions. Work in my lab identified SIRT6 as a critical chromatin deacetylase, repressing glycolytic
and ribosomal genes to control metabolic homeostasis. We also found SIRT6 as a major tumor suppressor in
multiple cancers, inhibiting glycolysis (Warburg effect) and developmental genes. Through all this work, I
pioneered the concept that metabolism and epigenetics crosstalk in cells, a field now explored by
hundreds of laboratories. Through the years, we also explored roles for chromatin in DNA repair and
development, including the first human syndrome of SIRT6 deficiency; we discovered SIRT6 as a driver of
transcriptional pausing, and more recently discovered that metabolic adaptations in cancer occur only in tumor
propagating cells, thus defining metabolism as yet another feature of cancer heterogeneity. Overall, my
laboratory has provided innovative insights that changed the way we think about metabolism and chromatin
dynamics. Work from us and others defined that availability of Acetyl-CoA is regulated in sub-cellular
compartments, in order to secure a sufficient source in the nucleus for histone acetylation reactions. Notably,
and in contrast to acetylation, despite methylation reactions being the most abundant modification in DNA and
histones, how levels of the universal methyl donor S-Adenosyl-methionine (SAM) is regulated remains
completely unknown. Strikingly, we have found in preliminary work that the enzymes modulating SAM appear
to shuffle between different cellular compartments depending on nutrient conditions, an adaptation that
appears to be critical both in normal and transformed cells. In the past decade of work, we contributed
significantly to the understanding of acetyl-modifications in chromatin and its connection the cellular
metabolism. In the next few years, we will take advantage of novel metabolic sensors and reporters, high-
resolution mass spectrometry and biochemical approaches to investigate how one carbon metabolism is
modulated in cells, how different cellular compartments cope with changing nutrients, and whether and how
metabolic enzymes are mobilized inside cells to be part of nuclear complexes in order to provide in situ SAM
for locus-specific methylation reactions. Despite SAM being a central metabolite in one carbon metabolism and
the universal donor for methylation reactions, how its availability influence epigenetic modifications and vice
versa, how chromatin dynamics dictate SAM metabolism, remains virtually unknown. Given the critical roles for
DNA and histone methylation in every aspect of organismal biology, from early development, to cellular
differentiation, cancer and ageing, our results will provide critical new insight into the molecular mechanisms
connecting these chromatin modifications to nutrient availability and metabolism.

Public health relevance
PROJECT NARRATIVE For the past fifteen years, studies from my laboratory have identified novel crosstalk between cellular metabolism and the ability to activate and silence genes by modulating chromatin compaction through availability of the metabolite Acetyl-CoA. Notably, and in contrast to acetylation, despite methylation reactions being the most abundant modification in DNA and histones, how levels of the universal methyl donor S-Adenosyl-methionine (SAM) is regulated remains completely unknown. In the next few years, we will take advantage of novel metabolic sensors and reporters, high-resolution mass spectrometry and biochemical approaches to investigate how one carbon metabolism is modulated in cells, how different cellular compartments cope with changing nutrients, and whether and how metabolic enzymes are mobilized inside cells to be part of nuclear complexes; these results will provide critical new insight into the molecular mechanisms connecting these chromatin modifications to nutrient availability and metabolism.